Administrative Supplement for Award 93818 (R01GM144578)

PROJECT SUMMARY
This supplement requests a Vitrobot 5 plunge freezer for the parent grant (GM144578), which will allow to apply
a new approach, cryo-electron microscopy (cryo-EM) to the parent grant, which investigates how the cell nucleus
is bi-directionally transported and positioned in a cell cycle specific manner, a process that is important for cell
cycle control as well as brain and muscle development. The importance of nuclear positioning for brain and
muscle development is underscored by the fact that human disease mutations of proteins engaged in the
transport of the nucleus cause severe brain and muscle development diseases, including spinal muscular
atrophy, which is the most common genetic cause of death in infants. Yet, it is unknown how teams of opposing
motor complexes collaborate to achieve correct timing, directionality and velocity of transport.
We plan: 1) To establish how motility of the motor complex dynein is modulated by dynein adapter/cargo
complexes and by the opposite polarity motor complex kinesin-1. 2) to establish a structural basis for recognition
of the cell nucleus as cargo by dynein adapters. 3) To establish whether the opposite polarity motors dynein and
kinesin-1 are recruited in a cooperative manner to the nucleus.
Cryo-EM was already proposed in the parent grant as an alternative approach for structure determination and
will enable the PI to expand her structural studies to larger complexes including full-length dynein adapter
proteins and intact motor complexes. With the current approach, that combines X-ray crystallography and NMR
for structure determination, the PI has been limited to structural studies of minimal complexes with truncated
fragments. Cryo-EM will increase the impact of all three aims of the parent grant since structures of intact
complexes will reveal a greater level of mechanistic insights compared to truncated complexes. This is
particularly important for the proposed aims which plan to establish the activation and cargo-recognition
mechanism of BicD2, as well as how bi-directional transport of the opposite polarity motors kinesin-1 and dynein
is regulated by the adapter proteins.
Our study serves as a model system to understand how cargo adapters regulate the motility and directionality of
cargo transported bi-directionally by both dynein and kinesin-1, which is important as these motors facilitate a
vast number of cellular transport events that are essential for chromosome segregation, signal transmission at
synapses, brain and muscle development. More specifically, results will establish how correctly timed bi-
directional transport of the nucleus is regulated, which is crucial for cell cycle control, muscle and brain
development. Mutations of proteins of these pathways cause devastating neuromuscular diseases, and results
will help devise therapies for these diseases.

Public health relevance
PROJECT NARRATIVE This project requests a Vitrobot 5 hat will significantly benefit the proposed research activities of an NIGMS- funded project. Results of the proposed research project will establish regulatory mechanisms for dynein and kinesin-1-dependent transport of the nucleus, which can be targeted to treat devastating neuromuscular diseases, including amyotrophic lateral sclerosis (ALS), hereditary spastic paraplegia and spinal muscular atrophy, which is the most common genetic cause of death in infants.